Pediatric Oncology Branch Clinical Care and Education

The majority of my efforts and responsibilities relate to the duties of Clinical Director of the Pediatric Oncology Branch. In that capacity, I oversee the pediatric oncology clinical service at the NIH Clinical Center and have budgetary responsibility for and supervise the Branch clinical fellows, nurse practitioners, and patient care coordinator. I also direct the NCI fellowship training program in pediatric hematology/oncology, which is a joint training program with Johns Hopkins University. I supervise and mentor the 21 fellows in our Accreditation Council for Graduate Medical Education (ACGME)-accredited training program.